Genome Editing and Animal Models

PROJECT SUMMARY / ABSTRACT
Genetically engineered animals and cell lines are widely used as models to define the mechanisms underlying
cancer etiology and progression and to evaluate strategies for cancer treatment and prevention. The Genome
Editing and Animal Models Shared Resource (GEAM) has served as a shared resource for the University of
Wisconsin Carbone Cancer Center (UWCCC) for over three decades and is one of the elite facilities in the United
States to offer the comprehensive services required to generate, characterize, and preserve genome edited
animal models. GEAM’s mission is to make state-of-the-art genome editing technologies for animals and cell
lines as well as cryopreservation services accessible to UWCCC members. Specific Aim 1 is to generate
novel, highly relevant, genome edited or transgenic animal models of human cancers. GEAM staff serve
UWCCC members in all aspects of experiment planning, including the design of efficient approaches to achieve
the desired genome manipulation using CRISPR, homologous recombination, and transgene-based
approaches; the identification of animals that carry the desired genome edit or transgene; and the minimization
of off target edits. Our extensive experience in reproductive biology, embryo manipulation, and animal husbandry
enable GEAM to edit the genomes of mouse and rat strains that exhibit low reproductive capacity. Specific Aim
2 is to develop clonally derived, genome edited, cell lines for use in cancer research. In the current cycle,
GEAM established a pipeline that is capable of editing the genome of a wide variety of established cell lines and
implemented a state-of-the-art automated clone tracking system. Specific Aim 3 is to provide state-of-the-art
reproductive biology services that enable animal model banking, recovery, and sharing. GEAM’s sperm
and embryo cryopreservation capabilities reduce animal husbandry costs and allow recovery of cancer models
through embryo transfer or in vitro fertilization. Rederivation of rodent models eliminates pathogens that may
compromise research or prevent animal model importation into campus vivaria or sharing between collaborators.
In the current cycle, GEAM has continued to modernize our infrastructure through purchases of new equipment
using institutional support, adopted the latest and most advanced genome editing methods, and added highly
trained staff to best meet the increasing and technically challenging needs of our users. Thirty-nine unique
UWCCC program members were served by GEAM during the current Cancer Center Support Grant (CCSG)
funding cycle. Support from the CCSG enables GEAM’s services to be tailored to the unique needs of UWCCC
members and provided at costs below those of commercial vendors or similar cores at other research
universities. GEAM’s first rate, cost effective, services enhance the ability of UWCCC investigators to conduct
innovative research and advance the strategic mission of the Center. Data from biennial surveys of UWCCC
members indicate GEAM’s services are high quality and critical to our members’ research.

Public health relevance
PROJECT NARRATIVE Per PAR-21-321 instructions, this component is not required.